Biology and Biochemistry of the Microtubule Cytoskeleton

PROJECT SUMMARY/ABSTRACT
Biology and Biochemistry of the Microtubule Cytoskeleton
Microtubules are cytoskeletal polymers that are vital for a wide range of cellular functions. They serve as tracks
for microtubule-based motor proteins (i.e., kinesin and cytoplasmic dynein), and perform work when their ends
attach to subcellular structures such as kinetochores. Most microtubule-based processes rely on assembly of
microtubules into higher order structures such as the mitotic spindle. This in turn depends on cellular factors
such as microtubule-associated proteins (MAPs) and microtubule motors, which bind microtubules and organize
them in three-dimensional space. How MAPs and motors drive assembly of microtubule-based arrays is not fully
understood, particularly under conditions of stress. In addition, the complexity of the microtubule system is
augmented by post-translational modifications (PTMs) that are “written” onto microtubules; PTMs alter the affinity
of MAPs and motors for the microtubule lattice, providing a mechanism to create functionally distinct subsets of
microtubules. Our research is focused on understanding how MAPs and motor proteins engage the MT
cytoskeleton to orchestrate essential cellular processes. To address this and fill gaps in our knowledge we: (i)
Discovered a second pathway that drives assembly of the mitotic spindle, and developed inhibitors against a
motor protein that plays a key role in this pathway; (ii) Developed a screening pipeline to identify proteins that
bind to microtubules in a manner that depends on tubulin PTMs; and (iii) Identified a mechanism that may explain
how tubulin PTMs are written onto the microtubule lattice. The research proposal benefits from our expertise and
will combine in vitro reconstitution and cell biology approaches to address long-standing questions: (a) How do
MAPs and motor proteins work together to build the mitotic spindle?; (b) What are the functional outputs of tubulin
PTMs?; and (c) How are MTs selected for post-translational modification? Our research will provide new insights
into fundamental mechanisms that regulate the biological and biochemical properties and functions of the
microtubule cytoskeleton and uncover general principles that inform on other cellular processes (e.g.,
microtubule organization in neurons).

Public health relevance
PROJECT NARRATIVE Biology and Biochemistry of the Microtubule Cytoskeleton The microtubule cytoskeleton is essential for a wide range of biological processes in all eukaryotic cells. The functions of microtubules are facilitated by microtubule-associated proteins (MAPs) and molecular motors that organize microtubules in three-dimensional space or use them as tracks for intracellular trafficking, and are extended by a constellation of tubulin post-translational modifications that act to regulate MAP/motor protein-MT interactions. We work to establish how the cellular system of MAPs, motor proteins, and tubulin PTMs organize MTs to drive essential cellular processes such as mitosis.